Oncometabolites, DNA Repair, and Cancer

We have discovered that elevated levels of the metabolites 2-hydroxyglutarate (2HG), succinate, and
fumarate in human cancers suppress homology-dependent repair (HDR) of DNA double-strand breaks (DSBs).
2HG is produced at high levels by the neomorphic activity conferred by isocitrate dehydrogenase-1 and -2
(IDH1/2) mutations in gliomas, sarcomas, cholangiocarcinomas, and acute myeloid leukemia. Elevated levels
of fumarate and succinate are found in familial cancer syndromes associated with renal cell carcinomas and
paragangliomas/pheochromocytomas, respectively, and are linked to germline mutations in genes encoding
the Krebs cycle enzymes fumarate hydratase (FH) and succinate dehydrogenase (SDH).
We found that elevated 2HG, fumarate, and succinate suppress HDR by competing with a-ketoglutarate
(aKG) to inhibit KDM4B, a histone lysine demethylase that acts on trimethylated histone 3 lysine 9 (H3K9me3).
Inhibition of KDM4B results in broad H3K9me3 hypermethylation across the genome, masking the H3K9me3
chromatin signal at the DSB that is essential for recruitment of TIP60 and other factors to initiate HDR. This
work was funded by this grant and published in Science Translational Medicine, Nature Genetics, and Nature.
Our finding of oncometabolite-induced HDR deficiency identifies defective DNA repair and consequent
genomic instability as an unexpected mechanism of carcinogenesis caused by elevated metabolites, and it
suggests that IDH1/2, FH, and SDH mutations in human malignancies can be exploited by synthetic lethal
targeting with poly-ADP-ribose polymerase inhibitors (PARPi). Our work has therefore provided a novel and
previously unsuspected therapeutic strategy for these malignancies that has been rapidly translated into
multiple new clinical trials testing the efficacy of PARPi in oncometabolite-producing tumors. This highlights the
significance of our work and its relevance to human health.
In Aim 1 of this renewal application, we will determine the scope of oncometabolite-induced HDR
deficiency in human cancers by testing specific hypotheses regarding metabolism-associated genes that are
either mutated or overexpressed in human cancers and assaying their impact on DNA repair. If successful,
these efforts will identify additional malignancies with previously unanticipated vulnerability to PARPi that can
be rapidly translated into the clinic. In Aim 2, we will discover and optimize new therapeutic strategies for
oncometabolite-producing tumors, via mechanistic and pre-clinical studies. We will test for synthetic lethality
and synergism, building on an initial small molecule screen, promising preliminary data, and specific
mechanistic hypotheses. We will evaluate potential therapies in cell and mouse tumor models to guide new
clinical approaches for these tumors. This work will define the landscape of oncometabolite-producing human
tumors, accelerate the rational design of new therapeutic strategies for these malignancies, and highlight
agents to bring forward for future clinical trials.

Public health relevance
We seek to identify novel connections between metabolism and DNA repair in human cancers. We have discovered that mutations in genes associated with metabolism that are either inherited or occur in cancers confer a DNA repair deficiency and a previously unexpected vulnerability to the class of anti-cancer agents called PARP inhibitors. In the proposed work, we will uncover new connections between metabolism and DNA repair in human cells and develop new ways to treat metabolism-driven cancers in a targeted manner to advance effective new therapies.